Can a radical transformation of preventive care reduce mortality by 20% in low SES populations? Preparatory work focusing on AUD/heavy alcohol use, HIV risk, and cardiovascular risk

Socioeconomic status (SES)-related health disparities are worsening substantially in the U.S. and elsewhere,
including Canada, Australia, New Zealand, Japan, Korea, Hong Kong, and even egalitarian Nordic European
countries with robust social safety nets (Denmark, Norway, Sweden, and Finland).
Preventable mortality is difficult to mitigate for a multitude of reasons, including numerous determinants at
individual, interpersonal, community, and societal levels. However, there is some cause for optimism based on
the potency of action levers at the individual level. Among SES- and race/ethnicity-related health disparities in
the U.S., 11 preventable conditions cause >50% of mortality. Further, our preliminary modeling work suggests
that only 9 prevention goals are required to attain 40% mortality reduction from these 11 conditions, resulting in
20% mortality reduction overall, because of interdependencies and common pathways. For example, alcohol
use disorder and/or heavy drinking impacts not only liver failure, but also behavioral consequences such as
sexual risk-taking and medication nonadherence.
However, attaining 20% mortality reduction would require a radical transformation of preventive care, such as
what we propose, focused on personalization, navigation, and compensation. Personalization means
maximizing individual-level benefit by modulating intensity of screening, frequency of screening; and intensity
or duration of response; navigation means reducing barriers posed by fragmentation of health and social
systems; and compensation means offsetting dependent care, time costs, and travel costs.
The post-R34-goal is a N=15,000 5-year RCT which would have adequate power to test the hypothesis of 20%
mortality reduction from personalization, navigation, and compensation. This proposed R34 is preparatory for
that goal, and focuses especially on alcohol use disorder and heavy drinking, HIV risk, and risk for
cardiovascular disease.

Public health relevance
NARRATIVE More people die of preventable disease in the United States than in other wealthy countries, especially among people with lower education or incomes. Previous research shows that 9 prevention goals could prevent most of these deaths. This proposal prepares to test whether free, convenient, and individualized training programs targeting these 9 goals could prevent deaths.